Causes and consequences of genomic instability in myelodysplasia

PROJECT SUMMARY/ABSTRACT
Myelodysplastic syndromes (MDS) are a group of age-related marrow failure disorders characterized by
cytopenia and anemia. It is estimated that 10,000 new cases of MDS are diagnosed in the United States each
year. This is caused by the functional decline of hematopoietic stem cells in the marrow because of acquired
genetic mutations that corrupt their ability to make blood cells effectively. Clinical management of MDS
remains challenging with limited treatments available, and stem cell transplantation remains the only curative
therapy. However, most patients are unable to receive transplantation due to advanced age and co-
morbidities. Thus, there is a pressing need to better understand the complexity of the disease which can lead
to the development of novel therapies. Somatic mutations in splicing factor genes including SRSF2, U2AF1,
SF3B1 and ZRSR2 are found in most patients with MDS. Patients carrying splicing mutation are generally
older, have inferior prognoses, and are at a higher risk of transforming to secondary leukemia. Recent studies
found that mutations in splicing factor genes trigger an elevated level of cellular R-loops, which consists of a
RNA:DNA hybrid structure and a displaced single-stranded DNA. While R-loops are natural by-products of
active transcription, if left unresolved, they could pose as a threat to genome integrity due to their propensity
to induce double strand breaks. Here, we propose to test the hypothesis that targeting R-loop-induced
genomic instability is an attractive therapeutic strategy in MDS cells that carry endogenous mutations in RNA
splicing factors. Our preliminary data suggest that cells mutated for splicing factors are exquisitely sensitive
to clinically approved PARP inhibitors, such as Olaparib, and a novel PARP1-specific inhibitor, AZD5305.
Moreover, we provide evidence that PARP can physically associate with R-loops to dampen R-loop-induced
genomic instability, and that PARP1 activity at R-loops could be used as a predictive biomarker for PARP
inhibitor response. This proposal has two specific aims. In Aim 1, we plan to dissect the underlying molecular
mechanisms of PARP inhibitor sensitivity in the context of splicing mutant MDS, and to test the therapeutic
potential of PARP inhibitors in pre-clinical MDS models. In Aim 2, we plan to expand and identify combination
therapy strategies with PARP and PARP1-specific inhibitors. We first plan to determine whether that
combining PARP and ATR inhibitors can induce synergistic effects in MDS cells with RNA splicing mutations.
Next, we plan to identify and test novel sensitizers of PARP1-specific inhibitor to evaluate optimal combination
treatment strategy using pre-clinical models. Successful completion of this proposal will lead to the validation
of new treatment options that can hopefully improve the outcomes MDS patients.

Public health relevance
PROJECT NARRATIVE Myelodysplastic syndromes (MDS) refers to a collection of clonal blood disorders characterized by ineffective production of mature blood cells by the hematopoietic stem cells in the bone marrow. Various genetic mutations, including those that participate in RNA processing, can corrupt the ability of bone marrow stem cells produce functional blood cells. In this proposal, we seek to understand the molecular causes and consequences of genomic instability caused by RNA splicing factor mutations, and to identify novel treatment options for MDS patients.